DSpace: Utilizing Data Science to Predict and Improve Health Outcomes in Pediatric HIV

Abstract
This administrative supplement to our U01HG114479 aims to support research to develop an evidence base
that will inform future policy directions on the utilization of electronic health records (EHR) including linkage
with potentially sensitive genomic data in pediatric research in Uganda and Botswana amidst a dynamic
consent landscape. Therefore, this project is specific to bioethics research in pediatrics. Pediatric research
is crucial for advancing healthcare but presents unique bioethical challenges due to children's evolving
capacity for assent and evolving consent processes. Data science holds promise for improving child health
outcomes in Africa but raises concerns regarding ethical considerations with pediatric EHR and genomic data
linkage. This study aims to address two bioethical questions: 1) the ethical, legal, and policy (ELP) issues of
using pediatric EHR data in research, and 2) the implications for consent and privacy when linking genomic
data with EHR in pediatrics research. In Aim 1 semi-structured interviews with key stakeholders and
document analysis will evaluate informed consent, data sharing practices, and vulnerabilities of children in
Ugandan and Botswanan research using EHR data. We will assess ELP considerations for pre-existing EHR
data use, including anonymization, governance, and secondary use ethics. In Aim 2 a discrete choice
experiment survey will assess public and researcher preferences regarding consent and privacy issues when
linking potentially sensitive genomic data with EHR in pediatric research. This study will provide evidence-
based recommendations to address ELP challenges and navigate the ethical landscape of data linkage in
African pediatric research. It will inform policymakers and researchers on promoting informed consent, robust
data governance, and participant privacy in data-driven research. Ultimately, this project strengthens the
bioethics research capacity for data science in Africa.

Public health relevance
Public Health Relevance Statement This research explores the ethical, legal, and policy issues of using electronic health records and linking genomic data in African pediatric research. The findings will inform policies and practices to protect children and improve ethical data use in African healthcare advancements.